Novel Nanoparticle Respiratory Tract Mucosal Vaccine

Summary
Bacterial and viral respiratory pathogens interact closely with mucosal surfaces. Specialized innate and adaptive mucosal
immune systems protect these surfaces and are the first line of defense for the body. One of the more important reasons for
the development of mucosal vaccines is the increasing evidence that stimulating and preparing local mucosal immune
responses is important for protection against infectious against diseases, such as tuberculosis. Although the entire immune
response repertoire needed for protection against Mycobacterium tuberculosis (Mtb) infection is not known, recent data in
animal models suggest that vaccine-induced CD4+ cells of the T helper 17 (Th17) cell subtype, which naturally traffic to
the airways, can accelerate the recruitment of protective Th1 cells and production of IFN, IL-17 and other cytokines.
Cytotoxic CD8+ and CD4+ T cells also are important and can be assessed via levels of antigen-specific induction of perforin,
granzyme B, and granulysin. In addition, IgA and IgG mucosal antibodies have been shown to interfere with the progression
towards disease with other respiratory pathogens and may act similarly against Mtb. The respiratory epithelial cell is a
primary target for mucosal vaccines. A major portion of the mucosa is comprised of cells that can provide a barrier function
and serve as sensors to detect dangerous microbial components through pattern-recognition receptors and transmit signals
to underlying mucosal cells to trigger innate and promote adaptive immune responses. Studies involving several Mtb
secreted proteins including HBHA, Rv3351c and ESAT6 have identified links between the initial interaction of the inhaled
pathogen with alveolar epithelial cells and the subsequent dissemination of the microbes from the lung. These Mtb proteins
also have been shown to generate important immune responses in mice given subcutaneous or intranasal doses.
Nanoparticles (NPs) are attractive mucosal vaccine/immunotherapy delivery vehicles due to the enhanced uptake by
antigen-presenting cells, the preferential draining of NPs to lymphatics rather than to the bloodstream, and depending on
size and composition, the ability of NPs to diffuse through mucus and cross mucosal barriers. Delivery of NP-based vaccines
to the respiratory tract may be a means of enhancing innate immune responses and will be the emphasis of this study. By
combining all three of these epithelial cell-targeting Mtb proteins on a NP vehicle combined with VacSIM® immune-
stimulating matrix plus adjuvant, and deploying as a mucosal booster vaccine to the subcutaneous BCG prime, we expect
protective cellular and humoral responses in animal lungs and significantly-elevated protection from Mtb infection
compared to that conferred by BCG vaccination alone. In Aims 1 and 2, we will evaluate the efficacy and immune responses
for multiple vaccine preparations and identify the two most protective which will be assessed in Aim 3 for safety, stability,
and then protective efficacy will be confirmed in guinea pigs. Our hypothesis is that by stimulating humoral and cellular
immune responses with our Mtb multi-antigen mucosal nanoparticle matrix vaccine, subsequent Mtb aerosol exposure will
result in reduced bacterial replication in the lungs and augment systemic immune responses generated by the BCG-priming
vaccine to more-effectively clear residual bacteria and decrease or prevent dissemination. We are confident this approach
will be successful against Mtb in two different animal models, and thus, lay the groundwork for subsequent non-human
primate trials.

Public health relevance
Narrative Until the unfortunate COVID-19 development, Mycobacterium tuberculosis (Mtb) was the number one cause of death in humans due to a single infectious agent. The current tuberculosis vaccine BCG is very effective in young children, but there is a need for a generally more-effective and longer-lasting vaccine, potentially as a booster to BCG. This proposal examines a novel intranasal subunit BCG booster vaccine comprised of multiple Mtb antigens that interact with the respiratory mucosa and are adhered to nanoparticles and combined with an immune-stimulating matrix.